Core 1: Biostatistics and Bioinformatics Core

PROJECT SUMMARY
The Biostatistics and Bioinformatics Core facility provides state-of-the-art statistical support for all Route 66
Endometrial Cancer SPORE investigators and projects. The Core will provide statistical support on all aspects
of study design, study execution and monitoring, database development and quality control, and data analysis
and interpretation. Biostatistics and Bioinformatics Core members have diverse expertise, a combined 57
years as faculty biostatisticians and bioinformaticians, and established long-term collaborations with SPORE
members at Washington University School of Medicine, University of Oklahoma Health Sciences Center, and
University of New Mexico. Their statistical expertise will support newly developing research themes of the
SPORE projects, such as Bayesian adaptive trial design, immunotherapy and target therapy trial design,
biomarker-guided personalized medicine study, next-generation sequencing, and high-throughput omics data
analysis. The Biostatistics and Bioinformatics Core team also has extensive expertise collaborating across
centers and in monitoring minority accrual, OnCore, REDCap, and data management/analysis for clinical
studies. In Aim 1, the Core will provide biostatistics and bioinformatics collaborations for SPORE projects and
Developmental Research Program studies. Core members have and will continue to regularly participate in
SPORE project investigator meetings and provide statistical support for designing studies and analyzing data.
Additionally, they will help Developmental Research Program awardees design studies and analyze data. In
Aim 2, the Core will provide biostatistics and bioinformatics support and training to early-career investigators
through the Career Enhancement Program. In their activities, the Core will draw on Clinical Trials Offices in
their respective Cancer Centers for multiple purposes: creating forms for data collection, uniform adverse event
reports, and tissue sample storage and management; and collating/integrating outputs from high-throughput
genomics to streamline data analysis and interpretation. In achieving its aims, the Biostatistics and
Bioinformatics Core will ensure that robust statistical methods and reproducible omics analyses are available
to support all Route 66 Endometrial Cancer SPORE investigators.